ONE ALPHA PARTICLE PASSAGE PRODUCE DNA LESION INTERACTION

We have developed a novel non-ionizing radiation method for introducing controlled numbers of DNA double strand breaks (DSB) into cells (1-3). Since the production of this damage is a consequence of the interaction of 365 nm light with DNA specifically modified to absorb this wavelength, damage to other cellular molecules is almost nonexistent. Thus we have a system in which such DSBs and (SSBs) are the only lesions produced and the lesions are randomly distributed in the cellular DNA. This provides us with the opportunity of examining the possibility of interaction between pairs of DSB-type lesions. Each cell containing a known number of photo-produced DSBs will be exposed to single a-particles with a range of LET's from 120 to 180 keV/um. Interactions between DSB, forming exchange-type chromosomal aberrations, will be detected by assessing cell survival - a known correlate with dicentric chromosomal aberration induction. Preliminary work in this area is already being carried out, studying the interactions between photo-induced DSBs and those induced by y-irradiation.